Coordination for Demonstrating Real-world Advancement in Genomics Operations Network (DRAGON)

The Network of Genomics-Enabled Learning Healthcare Systems (gLHS) Coordinating Center
will support a national, highly functional, integrated genomic medicine implementation
infrastructure that will enhance the quality, efficiency, and scientific rigor required to deploy and
refine interventions chosen by the Network. We are a team composed of leading content and
methods experts at Vanderbilt University Medical Center. We propose that a Demonstrating Real-
world Advancement in Genomics Operations Network (‘DRAGON’) will allow us to “we learn from
what we do and do what we learn.” We will support the clinical sites (CSs) in appropriately
embedding genomic medicine into routine workflows to promote more ready access to testing for
patients who would benefit. This requires assurance that clinicians understand and are willing to
act upon a strong evidence base utilizing vetted, established best practices. It necessitates a
landscape survey to identify the barriers and facilitators that the selected CSs may encounter. It
also demands engagement with patients and communities to help the Network communicate
genetic risk and how testing will improve their care. Functionally, 1) we will coordinate all Network
activities via our Operations Unit to ensure the collective is able to set, monitor and reach
programmatic goals. This will include supporting site communications, establishing oversight
committees, defining channels for NHGRI interaction, and facilitating network evolution. 2) We
will work with the CSs to select and optimize Network projects through our Design and Outcomes
Unit. This group will offer statistical, methodologic, and operations expertise to promote both
master protocol development and tailored local context modifications. We will cooperatively
determine how best to refine and redeploy interventions after evaluation to foster cycles of true
learning. 3) We will institute and co-produce a shared technical gLHS architecture with our Data
and Informatics Unit and CSs. This standardized approach will be essential to enabling effective
collaboration, monitoring, and evaluation across sites. 4) We will implement the Engagement Unit.
This group will promote bidirectional, longitudinal engagement from diverse communities; help
CSs build and sustain trust; ensure strengths of each CS are nurtured and shared; facilitate
dissemination of findings; and encourage engagement with payors, providers, and health
systems. DRAGON efforts will broaden the clinical availability, appropriateness, and actionability
of genomic medicine interventions by creating a community of practice dedicated to continual
accountability, improvement, and enhancement in genomic testing utilization.

Public health relevance
Translating genomic discoveries into clinical practice is vital but riddled with challenges - slow adoption of guidelines, lack of diversity in studies, inadequate reimbursement policies, and more. By integrating world-class scientific expertise in genomics with success in learning healthcare system implementation and internationally recognized high quality coordination capability, Vanderbilt University Medical Center (VUMC) will create a unified, genomics-enabled, learning healthcare system (gLHS) Network. We will facilitate project selection and optimization, establish a shared technical gLHS architecture, adapt and tailor to meet various local contexts, and build trust through authentic partner engagement enabling the next frontier in precision medicine by making genomics a more readily accessible component of routine care.